Research and Methods Core

Abstract – Research and Methods Core
The Research and Methods Core (RMC) will provide scientific, technical, and regulatory expertise and support
to the STELLAR Center and specifically the Rapid Cycle Pilot studies, Field Trial, and Pragmatic Trial. The
RMC, through working groups lead by expert investigators, will provide critical guidance on all Center research
activities. It will oversee development, implementation, and evaluation of Center research, promote common
data elements, and work with the Administrative Core to facilitate dissemination of research findings. In
conjunction with the Clinical Practice Network, the RMC will develop and test the pipeline of patient entry into
telehealth promotion services such that patients and providers alike are aware and desire program entry, that it
is accessible to all, and that it garners enrollment of a diverse representation of cancer patients. Specifically,
the RMC will provide the expertise necessary to develop, integrate, and implement common and customized
digital tools to support telehealth intervention and assessment. The RMC will use mixed (qualitative and
quantitative), effectiveness, and implementation research methods and provide biostatistics and informatics
support for all research goals. It will additionally support development of grant proposals for novel projects;
improve quality, rigor, innovation, and cost-effectiveness of the proposed studies, and disseminate research
findings and evidence-based telehealth interventions, care delivery models, and/or implementation strategies
to multiple stakeholders. The STELLAR RMC will be comprised of 4 key working groups. The Telehealth
Behavioral Interventions Working Group will support the development and harmonization of intervention
materials and tools. The Measures and Methods Working Group will provide research management and
oversight as it pertains to measures, assessments, outcomes, and research methodology. The Informatics
Integrations Working Group will facilitate the design, development, and integration of electronic data capture,
common data elements development, and key technology tool integrations to optimize the telehealth workflow.
Finally, the Data Analytics and Biostatistics Working Group will provide data management, statistical support,
analytics, and economic evaluation for the Center’s projects, including novel method development and
evaluation. In sum, the STELLAR RMC will enhance productivity by enabling investigators to conduct their
funded projects more efficiently and effectively and support cutting edge research by supporting and facilitating
innovative tool, method, and measures development and dissemination.